Mechanisms of CD4 autoreactivity after checkpoint inhibition

ABSTRACT
The use of checkpoint inhibitors has altered the treatment landscape in oncology, leading to cures in previously
untreatable diseases. Checkpoint inhibitors block the function of the PD-1 and CTLA4 inhibitory receptors on T
cells to enhance the activation of T cells, particularly tumor-specific lymphocytes. However, non-specific immune
activation has no antigenic specificity and also induces immune-mediated adverse events (irAE) that resemble
spontaneous autoimmunity and involve any and all tissues. IrAEs cause significant morbidity and disruption in
the cancer treatment of oncologic patients and, at times, can be life-threatening. However, the occurrence of
irAEs is also associated with improved tumor regression. This challenge has created a pressing need to
understand the pathogenic mechanism of irAEs to allow for proper therapeutic management and better predictive
algorithms to identify patients that may develop these autoimmune toxicities. However, dissecting the
immunopathology of irAEs is limited by a lack of understanding of the antigenic targets of the autoimmunity. To
address this gap in knowledge, we have established a prospective cohort of patients treated with PD-1 blockade.
Unlike cross-sectional studies, our cohort is unique in its (1) size, (2) prospective nature (before and after PD-1
immunotherapy), and (3) longitudinal design (before and after irAE incidence). We find that almost all subjects
that develop irAEs after PD-1 inhibition have an increased abundance of naïve CD4 T cells at baseline, as well
as more pronounced activation of these naïve T cells following PD1 inhibition. No changes in CD8+ phenotypes
correlate with irAE’s. Secondly, we utilized a whole exome autoantigen screening array to identify multiple non-
tumor related targets unique to each subject’. Together, these data lead to our parallel hypotheses that 1)
immune mechanisms of CD4-dependent autoimmunity are similar between subjects and independent of the
target tissue except when 2) the target of autoimmunity is coexpressed in the tumor and the target tissue. In our
first Aim, we will focus on the phenotype of the CD4+ T cells involved in the development of post-treatment
autoimmune inflammatory arthritis. Single cell multiome assays paired with T cell receptor sequencing will
identify and characterize oligoclonal expansions. In parallel, putative autoantigens identified by autoantibody
screening will be used in activation-induced marker (AIM) assays to validate the presence of autoantigen-specific
CD4+ T cells. We hypothesize that autoantigens are specific to the individual rather than universal; however,
the phenotype of the autoreactive CD4+ T cells will be similar amongst individuals. Secondly, we will examine
the antigen-specificity and CD4+ T cell responses in subjects with lung cancer that develop pneumonitis or a
peripheral irAE. We hypothesize that pneumonitis will reflect preexisting target tissue damage and antigen cross-
reactivity with tumor; whereas other tissues reflect de novo autoimmunity induced by PD-1 blockade. These
experiments will define the biology of irAEs and establish a pathway for the analysis of antigen-specific
autoreactive CD4+ T cells and prediction of AEs.

Public health relevance
PROJECT NARRATIVE The use of checkpoint inhibitor drugs has altered the therapy of cancer, leading to cures in untreatable diseases. However, by reinvigorating the immune system, these drugs are also associated with immune- mediated adverse events that resemble spontaneous autoimmunity, are poorly understood, and limit the use of potentially lifesaving treatments. The goal of this proposal is to improve our understanding the biology of the T cells that cause these adverse events.